No-Show Prevention Practices in Dental Care Settings Serving Underserved Populations

Project Summary/Abstract
Dental settings have been plagued with persistent no-show rates that are associated with low quality of care,
inadequate care access, and inefficient use of organizational resources for the patients and organizations that
need them most. Patient appointment no-shows are particularly pronounced in organizations that service
underserved populations. Studies documenting strategies to reduce no-shows in dental settings are limited,
with organizations reporting difficulty in replicating the findings, particularly in diverse patient populations. In
this study, a team of researchers from the Marquette University School of Dentistry and the Center for Health
Enhancement Systems Studies (the Center) at the University of Wisconsin–Madison College of Engineering
will test the effectiveness of three no-show reduction strategies using an innovative full factorial design that
allows for the simultaneous testing of different combinations of the no-show strategies. The intervention
strategies include a) using Motivational Interviewing techniques when scheduling appointments, b) conducting
reminder calls 24 and 48 hours before an appointment, and c) applying open-access scheduling, along with
other practices found to reduce no-shows in other sectors of health. The practices to test emerged from a pilot
conducted by the study team with dental clinics that primarily serve underserved populations. A significant
aspect of this study is the use of the NIATx Organizational Change Model (the NIATx model) to facilitate and
provide a standardized evidence-based strategy for no-show practice implementation and to address the
concern of the inability to apply proven no-show strategies. The UG3 will require a full two years to finalize the
study protocol and operations manual and formalize partnerships with 40 dental clinics. The UH3 will test if
different combinations of the no-show strategies of Motivational Interviewing, reminder calls, and scheduling
practices can improve no-show rates compared to treatment as usual (Aim 1). A mediational analysis will
examine whether using the NIATx model with fidelity and Organizational Readiness for Change mediates no-
show rates (Aim 2). The qualitative portion of the study will aid in interpretation of quantitative results and will
be used to gain a more in-depth understanding of the factors that promote or impede the implementation of the
no-show strategies (Aim 3). This trial will be among the first RCTs to test a combination of no-show strategies
in health care that is focused on the underserved populations where no-shows are most pronounced and have
the greatest adverse clinical consequences. The investigative team has successfully conducted a pilot study
on this subject and has considerable experience with large clinical trials. In summary, the study intends to
provide an evidence-based replicable approach to reduce no-show rates, with the goal of helping the dental
care field make organizational changes that support evidence-based care and improve care access.

Public health relevance
Project Narrative Persistent no-show rates contribute to the oral health disparities and inadequate access to dental care that disproportionately affect underserved populations. The proposed research will test the impact of three different strategies on no-show rates using an innovative full factorial design and a standardized implementation approach called the NIATx model. Findings from this study seek to provide an evidence-based approach to reducing no-shows and increasing access to dental care for underserved populations.